Animal Models Core - Roberts

Animal Models Core Abstract
The goals of the Animal Models Core are to ensure that standardized behavioral and biochemical operating
procedures are used across laboratories, to supply animals dependent on alcohol using chronic intermittent
ethanol vapor exposure (CIE model), and to provide blood alcohol level (BAL) determinations to The Scripps
Research Institute Alcohol Research Center (TSRI-ARC) investigators. In this renewal we are adding to our
mouse vapor chamber capacity to meet the increased needs of the research components. In addition, our gas
chromatograph system has been optimized as well as the means to request this service and provide BAL data
back to requestors in a timely and efficient manner. Centralization of these services prevents unnecessary
duplication of resources and effort, provides substantial time- and cost-savings for research components, and
promotes standardized quality control and increased consistency across projects. In order to continue the
important model development and optimization goals of the Animal Models Core, we plan to extend and
strengthen the phenotypic characterization of withdrawal and protracted abstinence in the mouse CIE model and
to examine a strategy for removing the need for pyrazole + ethanol injections prior to vapor exposure. The Animal
Models Core will promote integrative, efficient, and high-quality research that is the foundation of the ARC
research goals and mission.